Developing autologous iPSC-RPE based IND for AMD patients

The project had three main parts: (1) produce GLP-grade iPS cell lines and derived RPE from three AMD patients. Patient samples have been developed in to GLP-grade iPS cell lines and differentiated into RPE using a xeno-free medium. We have performed this process using samples from three patients to demonstrate process consistency. We have performed technology transfer to the NIH Clinical Center GMP facility; (2) demonstrate pre-clinical safety of the clinical product (iPSC-RPE transplant). This work is being performed in immunocompromised animals. iPSC-RPE transplants developed in part 1 will be transplanted in the sub-retinal space to determine acute and chronic, local and systemic safety profile of transplants. Histological analysis of the eye and other organs will be performed at different time points to identify potential damage or tumor or teratoma caused by iPSC-RPE transplant; (3) demonstrate pre-clinical efficacy of the clinical product (iPSC-RPE transplant). We have optimized a surgical procedure for transplantation of iPSC-RPE sheet in pigs. This surgery is performed using a four-port vitrectomy, similar to the procedure performed in humans. After removing the vitreous, a sub-retinal bleb is created by injecting saline in between the photoreceptors and the RPE. A small cut is made in the retina to transplant the iPSC-RPE scaffold in the sub-retinal space. Sub-retinal bleb is flattened using fluid-air exchange. The IND for this work was approved by the FDA in Dec 2019. The clinical protocol was approved by IRB in March 2020.

We have extended this work to develop a dual RPE-photoreceptor patch in collaboration with a small biotech company Opsis Therapeutics. We are performing proof-of-concept studies for co-culture of the two cell types and testing them in preclinical animal models.